2 College Truths & 1 Lie: Social Media Embedded Gamified Normative Re-education

Project Summary
Traditional social norms marketing campaigns (SNMCs), which seek to reinforce risk-reducing accurate
campus drinking norms via posters, have been a staple at universities for over two decades despite difficulties
in assessing campaign exposure, and boomerang effects associated with psychological reactance among heavy
drinkers. Further, exposure to alcohol content on Instagram and Snapchat has been shown to undermine
traditional normative re-education programs. Recent efforts have successfully drawn on the emerging
gamification literature to bolster student motivation and attention, decrease reactance, and thereby increase
the efficacy and real-world utility of one-dose personalized normative feedback (PNF). This proposal leverages
game mechanics identified in our previous projects to innovatively modernize SNMCs, which are universal
(campus-wide) and typically employed alongside psycho-educational and PNF interventions. Further, we plan
to utilize posts on Instagram and Snapchat to adapt the mode of delivery to specifically combat social media
(SM)-based alcohol influence. This innovative use of SM posts to deliver a SNMC game has the added benefit of
meeting students where they are (on Instagram and Snapchat) and is less resource-intensive than in-person,
online, and app-based norms intervention strategies. Additionally, this project will utilize targeted ads, which
are paid versions of posts, to innovatively addresses several limitations associated with traditional SNMCs,
such as an inability to conduct RCTs to evaluate the effectiveness of these campaigns within a campus and a
reliance on self-report to assess exposure to the campaign. The proposed project has two phases: (1)
development of the gamified SNMC, 2 College Truths & 1 Lie (2T1L) (Phase 1), and (2) a hybrid feasibility and
efficacy pilot RCT (Phase 2). 2T1L involves participants identifying an incorrect norm from a list of three
“facts” about first-year students; the game then corrects the misperceived norm and reinforces the correction
with graphics. Each round will include risk-reducing alcohol norms, either as truths or lies. 2T1L also included
features like points and leaderboards that increase interest, engagement, and believability, especially among
heavy drinkers who tend to be reactive to norms re-education. Participatory research methods will also be
employed to produce 2T1L to maximize appeal and relevance to first-year students. In Year 1, we will conduct a
norms documentation survey (N=400) to determine game norms (Aim 1a), and focus groups (N=50) to
identify game aesthetics preferred by first-year students (Aim 1b). In the beginning of year 2, we will conduct a
second set of focus groups (N=50) to test the 2T1L game and receive feedback to improve user experience of
2T1L prior to launch (Aim 1c). Phase 1 will culminate in a finalized version of the 2T1L SNMC to be evaluated
by a hybrid feasibility and efficacy pilot RCT (N=414) in Phase 2. Short- and long-term effects of the 2T1L
SNMC on reactance, norms, and drinking outcomes will be examined and findings will be used to inform the
need for further investigation of this program in a large multi-site RCT.

Public health relevance
Project Narrative Recent reports suggest that exposure to alcohol-related content on popular social media (SM) platforms, such as Instagram and Snapchat, can undermine commonly used college drinking norms intervention strategies not originally intended to address the onslaught of peer generated alcohol content available on these platforms. The proposed intervention strategy innovatively utilizes ads on these SM sites to introduce a microtargeted gamified normative re-education campaign that not only has the potential to mitigate risks associated with SM-related alcohol exposure, but also reduce the cost and increase the reach of this type of normative re-education program. Over the next three years, we will develop and program an innovative, engaging, interactive, and culturally relevant gamified social norms marketing campaign (2 College Truths & 1 Lie) for first-year students during the transition into college (Phase 1) and conduct a pilot trial to evaluate the feasibility and efficacy of the program (Phase 2).